HCD ON THE LTQ-VELOS PRO

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The LTQ-Velos ion trap mass spectrometer has recently been modified to allow performing higher-energy collision-induced dissociation (HCD) within the first quadrupole (Q00) in the intermediate vacuum region of the instrument. The new instrument is called the LTQ-Velos-Pro. HCD is a collision-based fragmentation technique which uses electric potentials to drive ions through a collision gas, in this case air. This beam-like fragmentation technique produces fragmentation spectra that are qualitatively similar to fragmentation patterns observed in triple-quadrupole instruments. We investigate the utility of performing HCD on the LTQ-Velos Pro for proteomics. In particular, we compare HCD and resonant CID, using several different experimental configurations, comparing the methods in the same LC/MS run and between different runs. We also evaluate the utility of HCD in producing library spectra that are well-matched to triple-quadrupole data and are thus well-suited to providing a transition from discovery-based proteomics to a more targeted approach.